Investigating putative antimicrobial product biosynthesis in a tick endosymbiont.

Project Summary
The blacklegged tick lxodes scapularis is the major vector of tick-borne disease agents in North
America, transmitting seven known human pathogens. However, despite its capability as a vector and
its geographical overlap with other ticks that host pathogenic spotted fever group rickettsiae (SFGR), /.
scapularis transmits no disease-causing Rickettsia species, and instead is widely infected by the
endosymbiont Rickettsia tamurae subspecies buchneri (Hardt et al. 2020; hereafter R.
buchnen). Presence of this symbiont has been proposed as the primary reason that/. scapularis is
rarely infected by nor transmits pathogenic members of the SFGR. Intriguingly, the R. buchneri genome
encodes putative antibiotic synthesis operons and a toxin/antidote module, which may contribute to the
symbiont's role in preventing rickettsial superinfection of its tick host. However, beyond bioinformatic
analyses, no investigation of the antibiotic activity of the products of these genes has been attempted.
In tick cell culture the presence of R. buchneri has been shown to prevent infection with the human
pathogen Rickettsia parkeri, and reduce infection by Anaplasma phagocytophilum and Rickettsia
monacensis. Besides the effect of the encoded genes for antibacterial antagonism, we also hypothesize
that the endosymbiont plays a role in modulating the immune response of its tick host to further reduce
infection by tick-borne pathogens. Both these mechanisms driven by R. buchneri may play important
roles in determining the tick's vector competence for human-pathogenic bacteria and shaping tick borne
disease epidemiology. Furthermore, identification of antimicrobial products from R. buchneri may result
in important leads for new drug development for the treatment of human infections.
To improve understanding of tick-symbiont interactions, research will focus on the following Aims:
Aim 1: Investigate regulation of the activity of antibiotic synthesis gene clusters and toxin/antidote genes
in R. buchneri under conditions of challenge with tick-borne pathogens in vitro, and assessment of tick
cell responses. Using qRT-PCR, the expression of R. buchneri's putative antibacterial antagonism
genes will be analyzed in tick cells when the symbiont is present only by itself or when tick cells are
additionally challenged with pathogenic R. parkeri. The expression of genes from multiple immune
pathways of the tick host will also be examined through RNAseq and single-cell genomics.
Aim 2. Discover the antibiotic natural products encoded in Rb genome. Homologous and heterologous
expression strategies will be employed to identify and produce the target natural products for
characterization. This research will clarify to what extent R. buchneri's antibacterial machinery is
employed during tick infection, whether the symbiont is involved in shaping /. scapularis immunity, and
will seek to identify and isolate the natural products synthesized by the symbiont.

Public health relevance
Project Narrative The blacklegged tick lxodes scapularis is North America's most important tick vector of diseases, but is also widely infected by the endosymbiont Rickettsia buchneri which is thought to prevent the tick from transmitting pathogenic Rickettsia. The symbiont's genome contains genes encoding putative antibiotic synthesis machinery, which might be one mechanism responsible for excluding other Rickettsia species, in which case the anti-rickettsial products might represent novel antibiotic compounds that could be developed to treat rickettsial diseases. This project will investigate how these antibiotic synthesis genes are regulated in the presence of pathogenic Rickettsia and seek to identify the potential antibiotic products of the synthesis machinery using heterologous expression approaches.